Modelling Enzymatic Electrostatic Field Effects with Coordination Chemistry

There is a fundamental gap in understanding the degree to which electrostatic fields within
metalloenzymes are able to influence the reactivity of transition metal-containing cofactors. A
growing body of evidence implicates electrostatic fields as the origin of a significant
portion of enzymatic activity, but to date, only theoretical models have evaluated such
electrostatic effects at the active sites of metalloenzymes. The continued existence of this
knowledge gap represents a critical shortcoming in understanding the means by which
metalloenzymes are able to perform strong-bond functionalization reactions, like N2
reduction to NH3 and selective C–H bond oxidation. The overall objective in this
application is to synthesize model compounds that will allow the magnitude and direction
of electrostatic fields to be correlated to critical steps in metalloenzyme-mediated
transformations. Research will be performed to test the central hypothesis, that strong,
local, electrostatic fields alter the valence electron distribution within
metal-substrate interactions, directing reactivity to the substrate and catalyzing bond
activation reactions. This hypothesis has been formulated on the basis of both literature
precedent from the organometallic and enzymology communities as well as preliminary data produced
in the applicant’s laboratory, which includes the synthesis of a new ligand framework capable of
stabilizing a mononuclear Cu:O2 analog of the CuM site in peptidylglycine α-hydroxylating
monooxygenase (PHM) in a manner consistent with the influence of strong, local
electrostatic fields. Guided by this background information, the central hypothesis will be
tested by first creating a library of model complexes in which non-Lewis acidic charged residues
are appended in the secondary coordination sphere of a central metal center. The synthetic
versatility of these ligands will allow for systematic changes to the location of the charged
residues with respect to the active-site of the metal center. Next, vibrational Stark spectroscopy
will be used to quantify the electrostatic field strength within the substrate-binding pocket of
the model complexes. The union of these data with investigations into coordination chemistry and
reactivity studies on O2-, NO-, and N2-bound model systems will be used to demonstrate the ability
of charged residues to shift the electron distribution within the valence manifold of metal
complexes. Overall, this work complements the PI’s broader research program focused on
seeking fundamentally new methods for controlling the reactivity of transition metal
complexes; this program includes a range of investigations into the use of electrostatic fields to
influence coordination chemistry and catalysis as well as the synthesis of multinuclear
cluster complexes that model the surface chemistry occurring on heterogenous catalysts. The
approach described in this application is innovative, in the applicant’s opinion, because it
provides a straight-forward means of both controlling and measuring the magnitude of
strong, local, electrostatic fields, while using these data to understand the action of
metalloenzymes. The proposed research is significant, because it is expected to provide data
that will contribute to understanding of the origin of enzymatic catalysis.

Public health relevance
The proposed research is relevant to public health because the fundamental discovery that electrostatic fields can impact catalysis within metalloenzymes is expected to lead to new classes of drug inhibitors, a better understanding of the genetic origin of diseases, and new biotechnological catalysts. Thus, the research is relevant to the part of NIH’s mission pertaining to developing fundamental knowledge that will help to elucidate the mechanisms by which enzymes function.